STORAGE AND STABILITY STUDY OF DRUG SUBSTANCE FOR CONTRACEPTIVE STUDIES

Storage and Stability study of drug substances (ex. Formulated Acyline and Kisspeptin) and products. These drugs will be used for contraceptive studies, contraceptive drug development for both Male and female.